Characterizing the Effects of Protein and RNA Variability in Molecular Function and Interactions

Project Summary
The scientific goals of the funded parent project of this proposal (R35 MIRA for ESI)
include the development of global probabilistic and computational models of biomolecules that
characterize and quantify the landscape of protein variability and their interactions. We aim to
elucidate the landscape of functional mutations, which is hidden within the much larger non-
functional space. We are using this functional landscape to engineer hybrid transcriptional
regulators, bio-sensors, the effects of mutations in disease-related proteins as well as to predict
specificity networks in two-component systems. Another important goal es to devise models to
characterize the sequence dependance on protein-protein and protein-nucleic acid interactions.
These models will allow us to encode and predict recognition from inferred landscapes and to
integrate our results with experimental technologies. Devising the spectrum of functional
biomolecular variability sculpted by evolutionary processes will be used to estimate the effects
of mutations in disease, antibiotic resistance, biomolecular sensor design and the impact of
sequence composition on interaction networks. As the research goals of the parent grant
benefits from algorithmic development, it also aims to make such developments available to the
scientific community. An undergraduate summer research experience will focus on the
development of a software pipeline to characterize protein-nucleic acid recognition and make it
publicly available online to facilitate analysis, prediction and discovery of nucleic acid sequences
that interact with key proteins, including some related to disease.

Public health relevance
Project Narrative In this proposal, an administrative supplement is requested to provide support for an undergraduate summer research experience connected to the goals of the parent grant. The project will focus on the development of a software pipeline to characterize protein-nucleic acid recognition and make it publicly available online. This experience will provide technical, operational, and professional skills in computational biology to a participant undergraduate student to strengthen the student research and development experience and aspirations for Ph.D. studies and a scientific career.